Roles of DNA polymerases delta and epsilon in replication, repair, and genomic fidelity

Abstract In eukaryotes, DNA polymerases (Pols) δ and ε play important roles in replication, but how these Pols contribute to the replication of the leading DNA strand has remained unclear. While the widely accepted model posits that Polε replicates the leading strand and Polδ replicates the lagging strand, we recently published evidence that Polδ replicates both the leading and lagging DNA strands. Nevertheless, important issues pertaining to their roles in replication remain to be resolved. Here we propose a number of highly innovative ideas and experimental approaches to unambiguously establish the roles of Polδ and Polε in replication. To determine whether Polδ or Polε replicates the leading strand, in Aim 1 we will analyze Pol?-generated errors on the two DNA strands in genes located at different chromosomal sites and genome-wide in a number of different yeast strains, and we will also examine whether Pol?-generated errors occur on the leading stand; in Aim 2 we will use mutations in the PCNA binding domain of Polδ and Polε to determine whether Polδ plays a major role in replicating both DNA strands or whether Polε replicates the leading strand, and we will carry out studies to analyze the genetic basis of the mutator phenotype of the pol2M-644G and the exonuclease defective pol2-4 Polε mutant alleles; and in Aim 3, we will determine whether as indicated from our genetic studies, Polε incorporates rNMPs on the leading strand during its roles in recombination and mismatch repair, and not during replication. Altogether, we expect that the proposed studies will resolve the outstanding issues relating to the role of Pols δ and ε in replication, and they will have important bearing on DNA replication and associated DNA repair processes and on the understanding of the roles of these Pols in genomic fidelity.

Public health relevance
Project narrative The aims of this proposal are to determine the roles of DNA polymerases  and  in DNA replication and repair. These studies will have a crucial bearing on the understanding of DNA replication and associated DNA repair processes and on the elucidation of mechanisms that govern genomic fidelity.